Point-of-care DNA diagnostics from raw samples

Project Summary
The proposed project will develop living biosensors for detecting and analyzing DNA at the single-
base level, without requiring sample purification or any equipment. DNA is the prime information
carrier for life, and DNA analysis provides valuable information for, e.g., diagnosing microbial
infections or tracking disease outbreaks. Many techniques exist for detecting and analyzing DNA,
but these generally require processing steps to extract and purify samples, and most require
expensive equipment and significant training and expertise. This proposal will transfer that
complexity into the biosensor itself, harnessing functions that evolved into living bacteria over
billions of years to pull DNA out of raw samples, analyze it, and produce easily read output. The
biosensors will pull in DNA using natural competence, and analyze it with single-base precision
using their endogenous CRISPR-Cas system. Upon detecting a target sequence, the living
biosensors will release thousands of signal molecules that can be detected using a lateral flow
assay, similar to a consumer pregnancy or Covid-19 test. Several target DNA sequences will be
used for demonstrations: urinary tract pathogens, E. coli, and Salmonella. The target
uropathogens are difficult to diagnose with standard culture tests. Using single-base sequence
analysis, the biosensors will subtype E. coli as likely pathogenic or likely commensal. A similar
strategy will be employed to detect single-base mutations responsible for the majority of
fluoroquinolone-resistant Salmonella isolates. DNA biosensing will be demonstrated in clinically
relevant human samples, without the extensive purification required by other methods. The
result will be a hybrid living biosensor / lateral flow assay that requires minimal sample
preparation, produces rapid results, and can achieve single-base resolution. The biosensors
developed in this project could find applications any time DNA monitoring is needed that is
inexpensive, requires minimal sample preparation, equipment, and expertise, or takes place at
the point of care. Examples include clinical diagnostics, monitoring disease outbreaks for public
health, or environmental monitoring, with particular benefits where resources are limited.

Public health relevance
Project Narrative This project seeks to develop bacteria into living biosensors that can detect and analyze DNA in dirty samples at low cost and with minimal labor and no equipment. The living biosensors will detect DNA of interest, analyze it for precise DNA sequences or differences, and produce easily read output on a lateral flow strip. The living biosensors coupled to a lateral flow assay, which will be as straightforward as a consumer pregnancy or covid test, will provide rapid diagnostic information even in low-resource settings, or when transporting samples to a central lab would add too much time or cost.